HORMONAL REGULATION OF MRNA STABILITY

DESCRIPTION (Adapted from the applicant's abstract): The studies proposed in this application will elucidate the biochemical mechanisms underlying the estrogen-dependent stabilization of apoII mRNA, by initially purifying the mRNA stabilizing protein to homogeneity and cloning its cDNA. This cDNA will be used to predict the amino acid sequence of the protein, to overproduce the protein and its mutated versions, and characterize its functions and mechanism of action at the biochemical level. Purification, cloning and characterization of these proteins are essential to our understanding of the molecular mechanisms underlying estrogen-regulation of apoII mRNA stability.